Restoring Mitochondrial Quality Control through Ceramide-Induced Mitophagy: A Potential Therapeutic Strategy for Alzheimer's Disease

Summary
Alzheimer's Disease (AD), the primary cause of cognitive decline, is intricately linked to impaired mitophagy, the
recycling of damaged mitochondria. This complex pathology may be driven by specific amyloid precursor protein
(APP) processing pathways that interfere with mitophagy, which could subsequently promote Tau
hyperphosphorylation and amyloid plaque accumulation. Ceramides, bioactive lipids synthesized by ceramide
synthase 1 (CerS1), have emerged as crucial regulators in mitophagy and mitochondrial homeostasis. Their role,
though pivotal, is not fully delineated. These lipids are known to influence mitophagy through specific signaling
pathways, possibly involving receptors such as CERT1, which mediates ceramide transport and distribution, thus
affecting mitochondrial health and function. Although ceramides are often criticized for being elevated in AD and
associated with negative outcomes, our research proposes a nuanced perspective, suggesting that it is not the
overall abundance but rather a disruption of ceramide homeostasis, specifically decreased ceramides at the
mitochondrial membrane, that may be driving the cell's increased ceramide production in an effort to upregulate
mitophagy. Regardless, the dysregulation in ceramide levels contributes to neuronal death and AD progression
by disrupting these pathways, yet the intricate details of these mechanisms remain to be elucidated. A novel
ceramide analog, LCL768, has been synthesized and shows promise in counteracting the detrimental effects of
mitochondrial APP accumulation. Preliminary findings suggest that LCL768 may independently modulate
ceramide signaling, enhancing the association between mitochondria and autophagosomes and thereby
potentially restoring effective mitophagy. The exact molecular action of LCL768 in AD is under investigation, with
hypotheses focusing on its interaction with ceramide pathways and mitochondrial membranes, influencing the
mitophagic process and neuronal survival. Our research will employ a range of experimental techniques to
investigate these mechanisms. Aim 1 will utilize genetic ablation in CerS1 knockout cell and mouse models,
alongside molecular assays to assess mitochondrial function and AD progression markers. Imaging techniques,
such as fluorescence microscopy, will be used to visualize mitophagy. Aim 2 involves pharmacological
intervention with LCL768 in Sh-Sy5y neurons and 3xTg AD mice, using behavioral tests to gauge AD symptom
alleviation and cellular assays to measure mitophagy enhancement. Expected outcomes from this study include
a deeper understanding of ceramide-mediated mitophagy in AD and the potential regulatory role of CerS1.
Demonstrating LCL768's efficacy in restoring mitophagy and mitigating AD symptoms could offer a novel
therapeutic avenue. The insights gained could impact our understanding of AD pathogenesis, highlighting new
targets for intervention and innovative treatments aimed at preserving mitochondrial health and neuronal
function, ultimately reducing AD morbidity.

Public health relevance
Our study delves into the intricate role of ceramides, a type of fat molecule in the brain, in Alzheimer's Disease. By exploring how these molecules affect the mitochondria of brain cells, we aim to open new pathways for treatments and research. These novel discoveries could significantly improve the lives of those impacted by this widespread condition, offering a future with better outcomes for patients and their families.